2022 Pediatric Dermatology Research Alliance (PeDRA) Annual Conference

PROJECT SUMMARY
Pediatric dermatology is a relatively young specialty that has lacked robust data about the natural history and
long-term outcomes of skin disorders that begin in infancy and childhood. In addition, evidence-based
guidelines of care, standardized treatment protocols, and FDA-approved therapies for the majority of pediatric
dermatologic disorders are sparse. The Pediatric Dermatology Research Alliance (PeDRA) was founded in
2012 to address these crucial yet unmet needs. PeDRA's primary mission is to create, inspire, and sustain
research to prevent, treat, and cure childhood skin disease. The long-term goal of PeDRA is to leverage such
research to improve the health outcomes of children with skin disorders. Annual conferences have been
integral to the success of PeDRA, providing a forum for educating investigators, identifying and prioritizing
research needs and opportunities, and developing and initiating innovative projects. A combination of didactic
lectures, expert-led interactive discussions, skill-building workshops, panel and poster sessions, and disease-
focused small-group sessions are the foundation of PeDRA's meetings. This proposal is for the 10th PeDRA
Annual Conference, set to take place in November of 2022 with the following aims: 1) Provide education and
engagement opportunities related to relevant research skills, building and leveraging community to advance
science, and integrating equity, diversity, and inclusion across pediatric dermatology research; 2) Advance
existing research projects and develop new research priorities within PeDRA's focus areas; and 3) Provide a
forum for the dissemination of final and ongoing research results from a broad group of investigators to a
diverse audience that includes patient stakeholders, industry representatives, and researchers from multiple
fields including potential NIH collaborators. The expected outcomes of this meeting are a more developed set
of research skills for current and future physician-scientists, enhanced productivity, strengthened networks,
and the conduct of high-quality research. These activities will accelerate the pace of pediatric dermatology
research, allowing clinicians to better understand, prevent and treat skin disease in children, and giving
patients and families options to manage diseases and make informed treatment decisions.

Public health relevance
PROJECT NARRATIVE Established in 2012, the Pediatric Dermatology Research Alliance (PeDRA) is a nonprofit research organization driven by the mission to create, inspire, and sustain research to prevent, treat, and cure childhood skin disease, and the PeDRA Annual Conference has been integral to the organization's growth and success since the first conference in 2013. In 2022, its tenth annual conference will continue PeDRA's work to educate and empower physician-scientists, trainees, and other stakeholders through an agenda that disseminates results, supports the identification of high-priority questions, and drives collaborative research forward under the theme of “Reimagining Community”. The conference will accelerate the pace of pediatric dermatology research in pursuit of PeDRA's vision of changing lives and healing children with skin disease through collaboration and discovery.